Investigating the role of frontal parvalbumin interneuron maturation in attentional development

Project Summary
Frontal cortical circuits undergo a protracted developmental process from adolescence to early adulthood to
establish cognitive functions such as attention and working memory. This developmental process is disrupted in
neurodevelopmental and psychiatric disorders. It remains poorly understood how key frontal circuits and their
associated brain networks are differentially recruited during cognitive behavior between adolescents and adults,
and how the dysregulation of frontal circuit development contributes to cognitive impairments. Identifying the
specific types of neurons in the frontal cortex that are crucial for attention development could lead to the discovery
of new therapeutic targets for treating cognitive impairments. Our long-term goals are to characterize the neural
circuit mechanisms of frontal cortex maturation that are essential for cognitive function, and to identify therapeutic
targets for mitigating cognitive impairments. Attention requires recruitment of the anterior cingulate cortex area
(ACA), a subregion of the frontal cortex. In adults, an increase in gamma oscillations between the frontal cortex
and sensory cortical areas is also crucial for attention. Among various cell types within the ACA, parvalbumin-
expressing interneurons (PVIs) exhibit neural activity that synchronizes with gamma oscillations, and this
synchronous activity is known to play a crucial role in attention control. Notably, ACA-PVIs undergo maturation
from adolescence to early adulthood, coinciding with the acquisition of improved attentional abilities, and
adolescent stress is known to negatively affect the maturation of ACA-PVIs. However, assessing attentional
performance in young mice is technically challenging because it typically takes months for mice to learn
conventional attentional behavior tasks. As a result, it is entirely unknown how the developmental changes of
ACA-PVIs are associated with in vivo network activity and attentional behavior across adolescence, and how
stress during adolescence affects PVIs and associated downstream neural activity during attentional behaviors
in adulthood. Our preliminary study overcame this challenge by applying an improved fast attentional testing
protocol which enabled the recording and manipulation of neural activity in adolescent mice performing the
attentional behavior task. Here, we will test the hypothesis that maturation of attentional performance following
adolescence depends on increasing recruitment of ACA-PVIs to synchronize ACA and visual cortex (VIS) activity.
We will also test the hypothesis that social stress during adolescence reduces recruitment of ACA-PVIs in
adulthood, leading to a decline in attentional performance, and that stress-induced attention deficits can be
alleviated through genetic manipulation of ACA-PVI maturation. To test these hypotheses, we will integrate
techniques for manipulating and monitoring cell-specific activity in developing mice with the aforementioned
attentional testing protocol.

Public health relevance
Project Narrative The frontal cortex develops more slowly than other sensory cortices, continuing to mature from adolescence into early adulthood. The maturation of the frontal cortex is crucial for exerting high levels of attention, but it remains unclear how this maturation affects the neural activity within the neural circuits responsible for attention during attentional behaviors. The proposed study aims to shed light on how the maturation of the frontal cortex contributes to enhanced attention by combining manipulation of frontal cortex maturation with neural activity recording from adolescent and adult mice during attentional tasks.